Defining Roles for Astrocyte Subpopulations in the Aging Brain

Abstract
Astrocytes are the most abundant and diverse glial cells in the adult brain, comprising 70% of
the glial constituency. Astrocytes perform essential tasks for normal brain function and
contribute to various neurological disorders, including neurodegenerative diseases such as
Alzheimer's disease (AD). However, their role in health and disease remains a mystery.
Recently, we found that Sox9 contributes to astrocyte-mediated regulation of brain circuits, and
demonstrated increased expression in reactive astrocytes in the human AD samples.
Furthermore, in preliminary data presented in the parent grant we found that Sox9 has an aging-
specific role in maintaining the functional integrity of hippocampal astrocytes. Together these
observation prompted us to further investigate whether Sox9 also plays a role in AD
pathogenesis. Critically, although the reactive astrocytes are closely associated with
degenerating neurons across multiple brain regions in patients with AD, it is largely unknown
how astrocytes contribute to the initiation and progression of AD and how astrocytic Sox9
regulates functions of astrocytes and reactive astrocytes in this context also remains undefined.
In this proposal, we will use newly generated animal models that enable us to overexpress or
knockout Sox9 selectively in astrocytes, during different stages of AD disease progression. Our
preliminary studies with these models demonstrated that astrocytic Sox9 plays an essential role
in Ab plaque accumulation at the onset of AD progression, where knockout of Sox9 enhanced
Ab plaque formation, while its overexpression suppressed Ab plaque formation. These results
lead us to the hypothesis that astrocytic Sox9 plays a central role in astrocytes and reactive
astrocytes during AD pathogenesis. To test this, we propose experiments to confirm Sox9
expression in the human AD brain and to use stage specific manipulations of Sox9 during early-
and middle- stages of disease progression to determine how it impacts AD pathogenesis and
associated behavioral- and circuit- levels alterations (Aim 1). To understand how Sox9 impacts
astrocytes associated with AD pathogenesis, we will examine a host of core astrocytic
properties including morphology, Ca2+ activity, and interactions with neurons in our stage-
specific, overexpression and knockout models (Aim 2). In sum, our preliminary observations
suggests that astrocytic-Sox9 contributes to AD pathogenesis, warranting further investigation
into when it exerts these effects and how it impacts astrocyte physiology across AD
progression.

Public health relevance
Narrative The focal point of this supplement is to understand the nature of astrocytic contributions to Alzheimer’s Disease (AD) pathogenesis. Given that patients with AD have reactive astrocytes closely associated with degenerating neurons across multiple brain regions, highlights the relevance of these studies to AD and the possibility that they will lead to new insights that can be applied to the possible treatment of AD. The transcription factor that we are studying Sox9 is present in human reactive astrocytes and has been implicated in reactive astrocyte responses in neurological diseases, further underscoring the connections between these studies and AD.